California Partnership for Personalized Nutrition

Project Summary: Poor diet and sedentary behaviors are associated with some of the leading causes of
premature death in the U.S. While nutritionists understand that there are a variety of eating behaviors that have
positive benefits to health and function in general terms, it has been difficult to tailor dietary recommendations to
the individual. Public health recommendations and marketing that aim to improve ‘diet quality’ (or complementary
outcomes, such as physical activity) have been hampered by a broad brush ‘one-size fits all’ approach without
distinguishing individualized needs. A big challenge to design of strategies for more personalized public health
is the paucity of large-scale interventions that have tested person-to-person differences in physiological
responses to standardized foods or diet patterns. The premise of the NIH Nutrition for Precision Health program
and this application to establish the California Partnership for Personalized Nutrition Clinical Center is that
variance in dietary patterns and physiological responses to patterns and specific foods are shaped by disparate
factors including complex genetic, microbiome, psychosocial, human ecology, and metabolic variables. We aim
to examine which factor or combination of factors influence responses to a test meal composed of strategic
ingredients that interrogate multiple biological systems in parallel, population-wide but with a consideration of
sub-groups that differ with respect to glucose control and microbiome (type 2 diabetic, pre-diabetic, and non-
diabetic persons). In addition, the differential (intra- and interindividual) responses to three disparate diets
(Mediterranean, low-carbohydrate, and high-carbohydrate) will be tested in free-living and domiciled conditions,
to characterize microbiota shifts and to associate diet with changes in multi-system physiology and
chronobiology. Finally, the study design also provides biospecimens for metabolomics, chemistry, and
microbiome; advanced metabolic physiology data; innovative app and wearable derived data; in addition to core
protocol EMR and genomic data suitable for high quality data modeling and advanced statistical/artificial
intelligence “big data” methods for discovery of personalized nutritional optimization.
The California Partnership for Personalized Nutrition established in this project grows out of the California
Precision Medicine Consortium (CAPMC), the All of Us Health Provider Organization in California,. The CAPMC
has established teamwork Statewide for recruitment and retention, with engagement of the great diversity of the
population of the State of California. This team, combined with the considerable experience in clinical nutrition,
feeding studies and micro- and macro-nutrient assessment, digital app and wearable technologies, modern
human ecology, community alliances, and food for health and wellness provides a combination ideally suited to
the goals of the Nutrition for Precision Health National program.

Public health relevance
Narrative Individuals with diverse backgrounds, behaviors, health issues, exposures and dietary habits may have different metabolic responses to food components and patterns of eating with important health and wellness implications. To identify predictive characteristics for specific nutritional responses with health risks or benefits to the individual, this study proposes to capitalize on the unprecedented scope and scale of the All of Us Research Program by adding dietary response assessment data in an ancillary sub-cohort, and by utilizing technologies for multi-omics, microbiome, and wearable devices. A prototype challenge meal and three distinct dietary patterns are proposed with the expectation that responses to both macro- and micro-nutrients in a diverse cohort will reflect the distribution of physiologic response phenotypes in the population.